Cerebral Palsy Clinic to You: Using Human-Centered Design to Develop and Pilot an Online Health Tool for Adults with Cerebral Palsy

PROJECT SUMMARY/ABSTRACT
Life expectancy for people with cerebral palsy (CP) is increasing – with adults with CP facing a dramatic shift in
healthcare access and services upon transitioning to adulthood. Adults with CP have unique healthcare needs
and risks beyond physical disability, including higher prevalence of many chronic conditions at younger ages
compared to the general population. Many of these chronic conditions are amenable to early detection and
treatment through primary care and preventive screening. However, individuals with disabilities including CP
face healthcare-related disparities, including lower rates of many preventive services and providers that do not
feel comfortable treating patients with disabilities. An online health tool for individuals with Down syndrome
improved adherence to healthcare guidelines with high levels of patient and provider satisfaction. Such a tool
would require significant adaptation for CP, but would be an ideal tool to adapt given its effectiveness in
another common lifespan condition. Dr. Cristina Sarmiento proposes to leverage implementation science
frameworks and human-centered design to adapt this online health tool for CP and develop Cerebral Palsy
Clinic to You (CPC2U) through the following aims: 1) qualitatively explore design and implementation
considerations for CPC2U among primary care providers; 2) adapt an online health tool (CPC2U) to promote
appropriate preventive care for adults with CP through human-centered design; and 3) pilot CPC2U to assess
acceptability and feasibility. This mentored career development award will support the transition of Cristina
Sarmiento, MD, an Assistant Professor of Physical Medicine & Rehabilitation at the University of Colorado, into
an independent physician scientist and her long-term career goal of becoming a national leader in lifespan
research for individuals with childhood-onset disabilities. To this end, Dr. Sarmiento will complete additional
training in these key areas: 1) qualitative methods for intervention design, implementation, and dissemination;
2) human-centered design to develop interventions with community involvement; and 3) designing and
conducting pragmatic clinical trials. The University of Colorado Anschutz Medical Campus provides a unique
research environment to conduct this research, supported by collaborative research partnerships between the
Adult and Child Center for Outcomes Research and Delivery Science (ACCORDS), University of Colorado
Hospital, and Children's Hospital Colorado. Dr. Sarmiento's nationally recognized team of mentors, Dr. Megan
Morris (disability equity research and qualitative methodology), Dr. James Feinstein (complex primary care
research and pragmatic clinical trials), Dr. Edward Hurvitz (lifespan disability and rehabilitation research), Dr.
Daniel Matlock (human-centered intervention design and implementation), and Dr. Kathryn Colborn
(biostatistics), will guide completion of the proposed training and research plan. This innovative proposal could
serve as a model for community involvement in intervention design for other lifespan disabilities.

Public health relevance
PROJECT NARRATIVE Cerebral palsy (CP) is the most common lifelong physical disability, and adults with CP are at high risk for many chronic conditions at younger ages compared to the general population. Because adults with CP experience difficulties accessing primary and preventive care to detect and treat these chronic conditions, this study will use implementation science and human-centered design to gather perspectives of primary care providers, adapt an existing online health tool, and pilot test the tool to facilitate patient-centered care and adherence to preventive services for adults with CP in the primary care setting. This career development award will ensure the growth of Dr. Cristina Sarmiento, MD, into an independent physician scientist who will expand knowledge in the field of lifespan research and improve health and healthcare for individuals with lifespan disabilities.